Imaging and Treating Inflammation in Stroke by Targeting Myeloperoxidase

DESCRIPTION (provided by applicant): Treatment of stroke is limited to a few approved therapeutic options, such as thrombolytic therapy, that have to be administered within rigid short timeframes resulting in the exclusion of many patients. Beyond the this timeframe even fewer effective treatment options exist. Therefore, extending current therapies and developing new treatment options would be highly desirable. Inflammation has been known to extend ischemic brain injury and adversely affect outcome. Although anti-inflammatory therapies can be effective in experimental models, thus far human trials have not shown a clear benefit. While the discrepancy is likely multifactorial, one contributing factor may be related to the use of broad anti-inflammatory agents rather than more focused therapies that target specific molecular pathways and enzymes demonstrated to be deleterious while maintaining the beneficial effects of the inflammatory response. A central obstacle in evaluating and implementing novel anti-inflammatory therapies for stroke is the lack of a noninvasive means to track the evolution of inflammation during stroke to observe the impact of targeted therapies in in vivo animal models and humans. Myeloperoxidase (MPO), a highly oxidizing and damaging enzyme secreted by many activated inflammatory cells, is found abundantly in stroke lesions. We have shown that the MR imaging agent, bis-5HT- DTPA-Gd (MPO-Gd) is highly sensitive and specific for detecting MPO activity. We found that MPO-Gd imaging can report and serially track MPO activity to obtain information that was previously only available from ex vivo studies. MPO-Gd imaging results correlated well with infarct volume and detected MPO activity in the infarct even 21 days post occlusion. In preliminary studies, wild-type mice treated with an MPO inhibitor as well as MPO deficient mice demonstrated substantial decrease in day 21 infarct volume. Therefore, we hypothesize that secreted MPO is a key biomarker for inflammation and infarct propagation, and that reducing MPO activity would improve stroke outcome. The overall goals of this proposal are to study the relationship between MPO and inflammation in stroke evolution and to develop treatment regimens to limit the inflammatory damage by modulating MPO activity/expression and in combination with thrombolytic therapy. The specific aims are 1) to establish MPO as an imaging biomarker for inflammation in stroke, 2) to assess MPO as a treatment target for stroke, and 3) to determine synergistic treatment regimens between MPO inhibition and thrombolytic therapy. The proposed investigations will provide a platform for the use of MPO molecular imaging in future investigations of basic pathobiology of inflammation in stroke and the impact of novel therapeutic interventions aimed at altering inflammation. Ultimately, the results of this proposal will set the stage for translational projects to benefit stroke patients by providing a noninvasive method to assess the inflammatory status during stroke, improving assessment of novel anti-inflammatory therapies in animals and in humans, and offering a new treatment target for stroke.

Public health relevance
PUBLIC HEALTH RELEVANCE: Because MPO-Gd is highly stable, nontoxic, and can be used to image MPO activity in a a wide range of clinically important inflammatory diseases, these investigations may provide the basis for application of MPO imaging for diagnostic evaluation of inflammation in humans and MPO inhibition for novel therapeutic interventions to improve outcome in stroke and other diseases. Because MPO-Gd is highly stable, nontoxic, and can be used to image MPO activity in a a wide range of clinically important inflammatory diseases, these investigations may provide the basis for application of MPO imaging for diagnostic evaluation of inflammation in humans and MPO inhibition for novel therapeutic interventions to improve outcome in stroke and other diseases. __SpecificAimsTextDelimiter__ IMAGING AND TREATING INFLAMMATION IN STROKE BY TARGETING MYELOPEROXIDASE SECTION 1. SPECIFIC AIMS Despite stroke being one of the most devastating and common causes of morbidity and mortality in the United States, treatment of stroke is currently limited to only a few approved therapeutic options, such as thrombolytic therapy, that have to be administered within rigid short timeframes resulting in the exclusion of many patients. Beyond this timeframe even fewer effective treatment options exist.1 Therefore, extending current therapies and developing new treatment options would be highly desirable. Inflammation can extend ischemic brain injury and adversely affect outcome.2-4 Although anti-inflammatory therapies can be effective in experimental animal models,5, 6 thus far human trials have not shown a clear benefit.7, 8 While the discrepancy is likely multifactorial, one contributing factor may be related to the use of broad anti-inflammatory agents rather than more focused therapies that target specific molecular pathways and enzymes demonstrated to be deleterious while maintaining the beneficial effects of the inflammatory response. A central obstacle in evaluating and implementing novel anti-inflammatory therapies for stroke is the lack of a noninvasive means to track the evolution of inflammation during stroke to observe the impact of targeted therapies in in vivo animal models and humans. Myeloperoxidase (MPO), a highly oxidizing and damaging enzyme secreted by many activated inflammatory cells, including activated macrophages, microglia, monocytes, and neutrophils, is found abundantly in stroke lesions.9 We have recently shown that the MR imaging agent, bis-5HT-DTPA-Gd (MPO- Gd) is highly sensitive and specific for detecting MPO activity.9-13 In an experimental stroke model we found that MPO-Gd imaging can report and serially track MPO activity to obtain information that was previously only available from ex vivo studies.9 MPO-Gd imaging results correlated well with infarct volume and detected MPO activity in the infarct even 21 days post occlusion.9 In preliminary studies, wild-type mice treated with an MPO inhibitor as well as mice deficient in MPO demonstrated substantial decrease in day 21 infarct volume. Therefore, we hypothesize that secreted MPO is a key biomarker for inflammation and infarct propagation after the initial ischemic insult, and that reducing MPO activity would improve stroke outcome. The overall goals of this proposal are to study the relationship between MPO and inflammation in stroke evolution and to develop treatment regimens to limit the inflammatory damage by modulating MPO activity/expression and in combination with thrombolytic therapy. This proposal seeks to validate MPO as an imaging biomarker for inflammation in stroke to distinguish strokes that would benefit from anti-inflammatory therapy, to establish a new method for inflammation imaging and anti-inflammatory treatment evaluation, and to extend and expand the current treatment options for stroke by targeting MPO. The specific aims are: Aim 1: To establish MPO as an imaging biomarker for inflammation in stroke. MPO is a highly oxidizing and damaging enzyme secreted by many inflammatory cells. We hypothesize that MPO activity as detected by in vivo molecular MPO-Gd imaging will reflect the inflammatory status in stroke over time and thus represents a key imaging biomarker for inflammation in stroke. We will profile and map the temporo-spatial relationship between MPO and other key inflammatory mediators using multi-modal molecular and cellular imaging approaches supported and validated by biochemical, histopathological, and immunological experiments. For these studies, we will use mice induced with stroke and sham-treated with saline in a longitudinal study to at least 21 days post infarct. This will validate MPO imaging to provide a new noninvasive means to track inflammation in stroke. Aim 2: To assess MPO as a treatment target for stroke. Expanding the current treatment options, during and beyond the first few hours after stroke, is urgently needed. We hypothesize that inhibiting MPO activity and/or expression will ameliorate inflammation and improve outcome. We will modulate MPO activity and expression in a longitudinal study using the following strategies/therapies: 1) inhibit MPO activity with the MPO- specific inhibitor 4-aminobenzoic hydrazide (ABAH), 2) decrease MPO expression with the drug lovastatin, 3) abolish MPO activity and expression using MPO deficient mice. We will explore the impact of these methods of immune modulation in suppressing inflammation and evaluate their efficacy in inhibiting secondary infarct propagation and improving outcome. Given that the peak inflammatory response occurs 3 days after the onset of a stroke,9 such a therapy has the potential to be extended to the significant percentage of patients who present beyond the short therapeutic window of thrombolytic therapy. Aim 3: To determine synergistic regimens between MPO inhibition and thrombolytic therapy. Thrombolytic therapy such as tissue plasminogen activator (tPA) can activate inflammatory cells and cause break down of the blood-brain barrier. We hypothesize that MPO inhibition can counteract the adverse effects of tPA administration. We will evaluate in longitudinal studies using the in vivo imaging and ex vivo assays established in the previous Aims to investigate 1) how tPA affects MPO and the inflammatory milieu over time and 2) whether combining tPA and MPO inhibition will work synergistically. This has the potential to maximize the therapeutic efficacy of the combined treatment strategies to improve outcome in stroke.